Study Of Antiretroviral Pharmacokinetics In Patients Fro

Many factors may alter pharmacokinetics, including cytochrome P450 phenotype, malnutrition, intestinal parasites, drug source (manufacturer), and drug storage conditions. In this study, in vitro assays of drug bioavailability will be performed using antiretroviral agents produced in several different countries. Pharmacokinetic profiles of several standard regimens will be assessed in several distinct geographic regions. If profiles are substantially different, studies will be performed to assess the cause, and whether dosage regimens different from those recommended in the US might be appropriate to maximize efficacy and safety.